Dissecting How Xenobiotics Act as Adjuvants for Oral Allergic Sensitization

PROJECT SUMMARY
Food allergies have been increasing at an exponential rate since 1960 for unknown reasons. We hypothesized
that modern xenobiotics that were widely introduced into the modern environment may be acting as allergic
adjuvants to break oral tolerance and cause allergy. This proposal will explore how certain non-steroidal anti-
inflammatory drugs (NSAIDs) are sufficient for oral allergic sensitization. The proposal will test the overarching
hypothesis that adjuvant NSAIDs are activators of the xenobiotic sensor, Nuclear factor erythroid 2-related
factor 2 (NRF2), in intestinal epithelial cells, which release IL33 to initiate the allergic response to coincident
food antigen. We will use a combination of genetic, pharmacologic, and mass spectroscopic approaches to
rigorously test this hypothesis. If confirmed, our work has major implications for why allergies are increasing
and could lead to new public health policies and novel therapies for the management of allergic diseases.

Public health relevance
PROJECT NARRATIVE Certain adjuvants lead to allergic sensitization, but their mechanisms of action are poorly understood. We discovered that a subset of non-steroidal anti-inflammatory drugs (NSAIDs) are sufficient as allergic adjuvants. We propose to mechanistically dissect how NSAIDs act as adjuvants to cause allergic sensitization.